Stem Cell Homing for Treatment of Female Pelvic Floor Disorders

DESCRIPTION (provided by applicant): Up to half the women in the U.S. experience female pelvic floor disorders (FPFD): stress urinary incontinence (SUI), fecal incontinence, and pelvic organ prolapse (POP). These conditions share common risk factors, including vaginal delivery, and therefore ought to be studied together. The lifetime risk of surgery for FPFD is 11%, with a re-operation rate of 29%. Since age, diabetes, and obesity are risk factors for FPFD, the aging US population and increasing prevalence of obesity and diabetes portend an FPFD epidemic in the U.S. in the coming decades. Female reproductive organs and the pelvic floor are rich in elastic fibers and undergo massive remodeling during pregnancy and childbirth. Lysyl oxidase-like 1 (LOXL1) is a protein essential for elastin remodeling and homeostasis. Unlike in normal mice, vaginal delivery in LOXL1 knockout (KO) mice results in POP and SUI, making it an ideal animal model of FPFD. Stem cells participate in normal repair processes and have the potential to be harnessed as a preventative therapy to facilitate repair after childbirth. We have preliminary data demonstrating that stem cells increase the elastin content of lower urinary tract tissues, suggesting the feasibility of stem cell administration to facilitate recovery after delivery and prevent FPFD. Cytokine gradients produced by injured tissues attract or home circulating stem cells to sites of injury, where they facilitate repair. Since the injuries that cause FPFD are too diffuse to be amenable to direct stem cell injection therapy, stem cell homing could be utilized to provide a viable therapy to facilitate repair after delivery and prevent FPFD. Recent research has demonstrated that stem cells can facilitate repair after injury by secreting paracrine-acting proteins such as growth factors. Identification of these factors may provide a viable noncellular therapy to facilitate repair after childbirth and prevent FPFD. We will utilize the LOXL1 KO mouse model to study if a cellular or noncellular stem cell-based reparative therapy could be utilized to prevent FPFD. The hypothesis to be tested in this project is that mesenchymal stem cells home to pelvic organs after delivery, facilitate recovery, and prevent resultant FPFD via secretion of paracrine factors. This hypothesis will be tested with the following Specific Aims: SA1. Determine the time course over which cytokines involved in stem cell homing and tissue repair are upregulated by the genitourinary organs after vaginal delivery or C-section delivery in LOXL1 KO mice. We will screen for upregulation of potential stem cell homing cytokines with a chemokine/chemokine receptor array system. Confirmation and localization will be made using RT-PCR and immunohistochemistry. SA2. Optimize the dose and timing of MSCs to best facilitate recovery from the maternal pelvic injuries of delivery and prevent FPFD. Fluorescently labeled MSCs will be infused at several time points after pup delivery in female LOXL1 KO mice. Outcomes will include staging of POP, urodynamics, quantitative histological morphometry assessment of elastin amount and pattern of clustering in genitourinary organs. SA3. Determine the receptor-mediated mechanisms of MSC homing & accelerated functional recovery from vaginal delivery. Female LOXL1 KO mice will undergo vaginal delivery and will receive an infusion of MSCs in which homing cytokine receptors have been knocked down via transfection with small interfering RNA (siRNA). The dose and time point of MSC infusion after vaginal delivery identified as most effective in SA2 will be used for the experiments of SA3. Outcomes of SA3 will be the same as in SA2. SA4. Determine the noncellular mechanisms of accelerated functional recovery from vaginal delivery. Infusion of MSCs will be compared to injection of concentrated conditioned media (CCM) from these stem cells. We will utilize both MSCs and CCM of MSCs generated from wild type and LOXL1 KO mice. We will also use siRNA to knock down secreted paracrine factors in MSCs and utilize both the MSCs and CCM from these cells. The dose and time point of MSC infusion after vaginal delivery identified as most effective in SA2 will be used for the experiments of SA4. Outcomes of SA4 will be the same as in SA2 & SA3. Significance. The maternal injuries of childbirth are diffuse and involve injury to many small structures, such as pelvic floor fascia as well as pelvic organs, making direct injection stem cell therapy to all these sites impossible. Therefore, therapies based on stem cell homing or on the systemic effects of stem cells may provide a viable method to facilitate repair of injured tissues and prevent FPFD. In addition, identification of the paracrine factors produced by stem cells and introduction of these factors after delivery may provide a viable noncellular reparative therapy to prevent FPFD. Thus, this research is highly innovative and is of high significance for FPFD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Up to half the women in the U.S. experience female pelvic floor disorders: stress urinary incontinence, fecal incontinence, and pelvic organ prolapse, but little is known about their pathophysiology and few nonsurgical treatments are available. In this project, we will use an animal model to determine if homing of adult mesenchymal stem cells could provide a possible nonsurgical treatment or preventative option. We will explore the possibility of making this therapy noncellular to avoid complications of cell therapy. This research is of high significance for development of improved therapies for female pelvic floor disorders. Narrative Up to half the women in the U.S. experience female pelvic floor disorders: stress urinary incontinence, fecal incontinence, and pelvic organ prolapse, but little is known about their pathophysiology and few nonsurgical treatments are available. In this project, we will use an animal model to determine if homing of adult mesenchymal stem cells could provide a possible nonsurgical treatment or preventative option. We will explore the possibility of making this therapy noncellular to avoid complications of cell therapy. This research is of high significance for development of improved therapies for female pelvic floor disorders. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Approximately half of elderly women in the U.S. will experience female pelvic floor disorders (FPFD), including pelvic organ prolapse (POP), stress urinary incontinence (SUI), and fecal incontinence (FI; (100). FPFD often appear in conjunction and share common risk factors, including vaginal delivery of children (65). Thus, they need to be studied together as a complex of related conditions. Despite their prevalence, current treatments are almost entirely surgical and have a high revision rate (65). Recent data suggests a link between elastin abnormalities and FPFD (27; 73). Lysyl oxidase like-1 (LOXL1) is one of the monoamine oxidases required for covalent crosslinking of elastin and has an essential role in elastin fiber remodeling (71; 88). We have determined that vaginal delivery in LOXL1 knockout (KO) mice results in POP and SUI and that increased parity increases the incidence of POP in LOXL1 KO mice (79; 87; 88). Caesarian-section (C-section) delivery decreases FPFD, similar to the clinical condition. We have also demonstrated disorganized elastin clusters after POP (79), further evidence of an association between elastin & FPFD. Stem cells participate in normal repair processes and therefore have the potential to be harnessed to facilitate repair of the maternal injuries of childbirth. Cytokine gradients produced by the injured tissues attract or home circulating stem cells to sites of injury, where they facilitate the repair process (50; 109; 114). Recent research has demonstrated that stem cells can facilitate repair after injury by secreting paracrine-acting proteins such as growth factors (Fig. 1) and suggest that stem cells can act systemically as well as locally, implying that localization of cells, may not be essential for facilitation of recovery (54; 127). Since vaginal delivery produces diffuse injuries to a variety of organs and tissues, injection of stem cells into a localized site of injury is not a reasonable option to facilitate repair. We have therefore investigated stem cell homing and have shown that IV injected adult mesenchymal stem cells (MSCs) home to the urethra after a simulated childbirth injury due to upregulation of stem cell homing cytokines in pelvic tissues (156; 157) and can accelerate recovery. We have also shown that MSCs injected into the urethra of rats that have undergone simulated childbirth significantly increase the elastin content and elastin organization, demonstrating the regenerative properties of these cells. However, rats do not develop POP, even after pup delivery or simulated childbirth injury, making LOXL1 KO mice a valuable model system to study the spectrum of FPFD. The goal of this revised R01 proposal is to investigate the mechanisms by which adult MSCs facilitate recovery and prevent FPFD in LOXL1 KO mice. Our Hypothesis is that: MSCs home to pelvic organs after delivery, facilitate recovery, and prevent resultant FPFD via secretion of paracrine factors. It will be tested with the following Specific Aims (SA): SA1. Determine the time course over which cytokines involved in stem cell homing and tissue repair are upregulated by the genitourinary organs after vaginal delivery or C-section delivery in LOXL1 KO mice. We will utilize a chemokine/chemokine receptor nylon membrane array system to screen for upregulation of potential stem cell homing cytokines after delivery in female LOXL1 KO mice. Confirmation and localization will be made using RT-PCR and immunohistochemistry. SA2. Optimize the dose and timing of MSCs to best facilitate recovery from the maternal pelvic injuries of delivery and prevent FPFD. Fluorescently labeled MSCs will be injected via the tail vein at several time points after pup delivery in female LOXL1 KO mice. Outcomes will include staging of POP, urodynamics including LPP testing for SUI, quantitative assessment of elastin clustering. Localization of stem cells in the genitourinary organs will be determined with immunofluoresence. Changes in the amount and pattern of elastin and smooth & striated muscle in the pelvic organs will be assessed. SA3. Determine the receptor-mediated mechanisms of MSC homing & accelerated functional recovery from vaginal delivery. Female LOXL1 KO mice will undergo vaginal delivery and will receive IV administration of MSCs in which homing cytokine receptors have been knocked down via transfection with small interfering RNA (siRNA). The dose and timing of MSC infusion after vaginal delivery identified in SA2 as most effective will be utilized. Sham groups will include rats that undergo vaginal delivery and are treated with MSCs transfected with scrambled siRNA or saline. Similarities in type & timing between the most effective MSCs and upregulation of homing cytokines in injured tissues (SA1) will be taken as partial validation of a receptor-mediated mechanism for homing. The outcomes of SA2 will be utilized. SA4. Determine the mechanisms by which MSCs modify the pathophysiology of FPFD. We will determine the mechanisms of action of MSCs with the goal of developing a noncellular therapy to prevent FPFD. Infusion of MSCs after delivery in female LOXL1 KO mice will be compared to injection of concentrated conditioned media (CCM) from these cells. SiRNA will be utilized to knock down secreted paracrine factors in MSCs. We will also determine if MSCs must express LOXL1 to prevent FPFD. Sham treatments will include MSCs transfected with scrambled siRNA, CCM from those cells, saline, and media. Long Term Goals. Systemic therapy could provide treatment to the site where it is needed with few side effects. Advantageously, noncellular methods could be developed based on the outcomes of this study, since the paracrine factors secreted by stem cells could potentially be used to accelerate recovery in the absence of cells. Future projects will include investigations of methods of translating this study to clinical trials. Postpartum SUI is highly predictive of FPFD years later even if the postpartum SUI resolves initially (9; 149). Therefore, postpartum SUI could be used as a predictor of women at greatest risk for development of FPFD. Women with postpartum SUI could be a population of initial candidates for an intervention that would both treat their current incontinence and prevent future FPFD. Fig. 1. Schematic representation of the steps involved in stem cell-based treatment of injured tissue (110). The stages begin with circulating stem cells (black with white nuclei) in the blood vessel and proceed to migration of stem cells into injured tissues. The process is completed with the release of paracrine factors into the injured tissues or differentiation of the engrafted stem cells into muscle cells.